Targeting early events in prostate cancer lineage plasticity

PROJECT SUMMARY/ABSTRACT
Prostate cancer is the most common non-cutaneous cancer in males. Prostate cancer cells are dependent on
a transcription factor called the androgen receptor (AR), which is activated by the androgens testosterone and
dihydrotestosterone. Accordingly, an effective treatment for patients with advanced prostate cancer is
androgen deprivation therapy, which blocks the effects of androgens, inhibits the AR, and halts the growth of
prostate cancer cells. Although this form of treatment is very effective for advanced prostate cancer, the stress
of this therapy will eventually lead to the prostate cancer cells developing resistance. In approximately 25-30%
of cases, the stress of prostate cancer therapy will cause the prostate cancer cells to transform into cellular
states where they no longer resemble the original disease. These prostate cancer cells take on features of
alternative cell types through a process called lineage plasticity. These lineage plastic prostate cancers are
very difficult to treat because they do not contain AR and there are no effective therapeutics available.
Additionally, the processes by which standard prostate cancer therapies can cause prostate cancer lineage
plasticity is poorly understood. This proposal seeks to understand the biology of prostate cancer lineage
plasticity and develop new therapeutic strategies to treat, prevent, or reverse this disease stage. Our
preliminary data demonstrates the stem cell transcription factor KLF5 is up-regulated by standard prostate
cancer therapies that inhibit the AR. Up-regulation of KLF5 enhances androgen-independent growth of
prostate cancer cells, as well as migration and colony formation phenotypes. Functionally, the transcriptional
program initiated by up-regulated KLF5 clashes with the transcriptional program activated by the AR. Because
the AR transcriptional program controls prostate cancer cell identity, KLF5 up-regulation breaks down this
identity and promotes very early steps in lineage plasticity of prostate cancer cells. We hypothesize that
targeting this early step in therapy-induced prostate cancer lineage plasticity will block later events that lead to
very aggressive, treatment-resistant manifestations of the disease. We have identified ERBB2 as a focal point
of this tug-of-war between AR and KLF5, and shown that ERBB2 inhibitors can block the oncogenic effects of
KLF5. To advance these findings and identify additional therapeutic vulnerabilities in this pathway, we propose
2 Specific Aims. In Aim 1, we will study induction of KLF5 and lineage plasticity phenotypes in CRPC. In Aim 2,
we will test therapeutic potential of blocking early steps in CRPC lineage plasticity. A successful outcome can
lead to rapid development of clinical trials testing these therapeutic strategies for treatment or prevention of
lineage plastic prostate cancer.

Public health relevance
PROJECT NARRATIVE Standard-of-care prostate cancer treatments targeting the androgen receptor transcription factor exert selective pressures that can lead to the emergence of lineage plasticity phenotypes that are difficult to treat and poorly-understood. This proposal seeks to understand the role and therapeutic potential of a stem cell transcription factor that is up-regulated by prostate cancer treatments and promotes early events in prostate cancer lineage plasticity. We will test the efficacy of blocking this stem cell transcription factor, as well as inhibiting its downstream targets, to treat, prevent, or reverse the emergence of lineage plasticity in prostate cancer.